Fas Ligand Cleavage regulates ocular homeostasis and glaucoma

The type II transmembrane protein Fas ligand (Fasl) was first identified as a death receptor ligand that induced
Fas+ target cells to undergo apoptosis. As such, its constitutive expression in the eye has historically been linked
to the phenomenon of immune privilege and its ability to kill activated eye-infiltrating Fas+ effector cells, or eye-infiltrating
Fas+ vascular endothelial cells. However, this notion is confounded by the fact that many non-hematopoietic
cell types in the eye, including retinal ganglion cells (RGCs), constitutively express Fas. In fact,
Fasl-mediated destruction of RGCs is a key factor in glaucoma pathogenesis, either by direct killing of RGCs
and/or by inducing the production of proinflammatory chemokines by Fas+ glial cells (eg. astrocytes), that recruit
proinflammatory cells to the retina and thereby causing neurotoxic inflammation. This apparent conundrum can
be explained if one accepts our hypothesis that constitutive metalloproteinase-mediated cleavage of
membraned-bound Fasl (mFasL), releases a soluble fragment (sFasL) that opposes the neurotoxic activity of
mFasL. This premise is supported by preliminary data showing: (a) mice with a gene-targeted mutation of Fasl
that eliminates this Fasl cleavage site (mFaslmice) develop accelerated glaucoma in spontaneous and
inducible glaucoma models; {b} in healthy eyes, retinal Fasl is constitutively cleaved, but in glaucomatous eyes,
retinal Fasl is membrane-bound; and (c) intravitreal injection of an AAV2-sFasL vector prior to disease onset
can prevent the development of glaucoma, while injection of AAV2-sFasL after disease onset can reverse
functional defects. Together, these data point to Fasl as an important therapeutic target for patients with
glaucoma. However, a number of key questions remain unanswered and will be addressed by the proposed 3
specific aims: (Aim 1) When and how is Fasl cleavage suppressed during the development and progression of
glaucoma and how do ADAM10 and TIMP1 in regulate Fasl cleavage ?; (Aim 2) To what extent does the direct
engagement of Fas, expressed by astrocytes and/or RGCs, contribute to the development of glaucoma?; and
(Aim 3) Can sFasL directly engage Fas to elicit a protective gene expression program? Our research strategy
will involve both accepted and novel experimental tools, including (a) sortase-tagged-Fasl mice (provide by Dr.
Ploegh}, that will greatly facilitate our ability to monitor mFasL vs sFasL protein levels in the eye, {b} Fas-flexed
mice crossed to RGC- and astrocyte/muller-specific ere-deleter lines, that will allow us to identify the importance
of these cells in the development of glaucoma; (c) allophenic (tetraparental) chimeric mice made by fusing Fas+
and Fasn•9 embryos, that will allow us to distinguish direct and indirect effects of Fasl engagement in the context
of glaucoma, and {d} AAV2-sFasL vectors that will allow us to determine if sFasL functions independently of
mFasL. The mechanistic insights gained from the proposed studies are likely to reveal improved strategies for
the effective manipulation of Fas/Fasl interactions in patients afflicted with glaucoma and other ocular disorders.

Public health relevance
Glaucoma is a chronic disease that leads to loss of vision following death of a specific cell in your retina, called a "retinal ganglion cell". Our research has identified a signaling pathway that is triggered during glaucoma that causes the death of these cells and we are studying the mechanisms by which this pathway causes death of these cells with the goal of developing novel targeted therapies for patients with glaucoma.